DISSEMINATION

The Albert Einstein Center for Synchrotron Biosciences has a new web page on the internet. The URL is: http://beam.aecom.yu.edu/phys&bio/csb1.htm. The web site provides a plethora of information about the Center and also contains a page of interesting related links. All of the Center's scientific programs are described in detail, including a special page that is updated frequently with the most recent scientific results. The entire Annual Report is available on the web site, including a complete list of this year's publications. The reader can also see pictures of the lab facilities and personnel and can find all contact phone numbers, fax numbers, mailing addresses, and Email addresses. Beamline users can view beamtime schedules, download forms for beamtime and lab requests, and read about the capabilities of X9A, X9B, and U2B. Finally, the page contains a powerful search engine for quickly finding the information requested. The web site is registered with most popular world wide web search engines, such as Yahoo, Alta Vista, Lycos, and Hot Bot.